Enhancing Drug Screening with Automated Single-Cell Electrophysiology and Contractility Measurements in iPSC-CMs

Cardiomyocytes (CM) derived from human induced pluripotent stem cells (iPSC-CMs) hold tremendous potential
for cell therapy, drug assessment, and understanding the pathophysiology and genetic foundations of cardiac
diseases. Despite this promise, new drug failures are predominantly due to safety issues. iPSC-CMs are
promising platforms for predicting cardiotoxicity due to their ability to model human cardiac function. Key
indicators of cardiac health, such as action potential and contraction force, are essential for distinguishing
between healthy and diseased states and are also predictors of cell maturation. However, current techniques,
including the gold standard of patch clamping, have significant limitations in this context. We propose an
innovative, automated system that integrates proven micro-electromechanical systems (MEMS) sensor pipettes,
automation, and machine vision to simultaneously and directly measure electrophysiological properties (e.g.,
action potentials) and contractile forces in single iPSC-CMs. This system will provide high-content analysis
(HCA) at the single-cell level, enabling the evaluation of iPSC-CM and drug-induced cardiotoxicity with
unprecedented efficiency. Compared to conventional patch clamping, which requires 2-4 hours per
measurement, our system will significantly reduce the measurement time to less than 2 minutes, greatly
enhancing performance and usability. The proposed system will democratize these complex measurements,
allowing any laboratory technician to conduct them with minimal training, unlike the conventional patch clamping
that demands a Ph.D.-level scientist due to its steep learning curve. To validate our hypothesis and advance this
technology, we have outlined three specific aims: (1) design and fabrication of the micro-pipette, (2) integration
of automation, machine vision, and sophisticated detection mechanisms, and (3) validation and application of
the system in iPSC-CM characterization and drug evaluation. This tool will revolutionize the current gold
standard, enabling robust electrophysiological and contractility measurements, streamlining data acquisition,
and ensuring high performance. Its applications span iPSC-CM research, drug discovery, and personalized
medicine, where it can analyze iPSC-CMs generated from a patient's tissue sample to predict individual drug
reactions, providing statistically meaningful insights for personalized treatment plans.

Public health relevance
We are developing an innovative automated system to study cardiomyocytes (heart cells) derived from stem cells, designed to quickly and accurately test how these cells respond to various drugs. This advanced tool measures both the electrical activity and muscle contractions of the heart cells, providing critical information about drug safety and efficacy. Compared to current methods, our system is significantly faster and easier to use, representing a substantial advancement in heart disease research and drug testing, thus promising to enhance the evaluation of cardiotoxicity and improve the development of safer and more effective therapeutics.